Chronic graft-versus-host disease

This project is a long-term clinical collaboration as part of a large intramural NIH effort to advance the study and treatments of chronic graft-versus-host disease (GVHD). Using clinical specimens (skin biopsies) as well as extensively phenotyped patient material, we aim to make important advances in the field. This has led to several published manuscripts since the last Annual Report. Advances in the last year include a comprehensive 2 part CME of cutaneous GVHD, safety of leukapheresis in GVHD pts., red cell distribution width as a prognostic marker of cGVHD, and predictors of kidney dysfunction in GVHD. A report on RNA seq of CGVHD fibrosis is under revision to JID Innovations.